Metabolism and Epigenetic Regulation are Couples in Transdifferentiation and Vascular Regeneration

Abstract
We discovered that nuclear reprogramming of somatic cells to a different somatic cell lineage, or
induced pluripotent stem cells, requires activation of inflammatory signaling within the cell. Specifically,
pattern recognition receptors (PRRs) such as toll-like receptors (TLRs) mediate a cell-autonomous
innate immune response via NFKb and IRF3. We found that this inflammatory signaling causes global
changes in the expression and/or activity of epigenetic modifiers so as to increase DNA accessibility
and fluidity of cell phenotype. Subsequent work has suggested that this process of “transflammation”
may be involved in vascular regeneration. Specifically, we have shown that fibroblasts in an ischemic
region can be transformed into endothelial cells (ECs) through a process we termed “angiogenic
transdifferentiation”. This process contributes to the recovery of perfusion in the ischemic region, as the
recovery of the microvasculature, and the restoration of blood flow in an ischemic region is antagonized
by factors required for angiogenic transdifferentiation (e.g., inflammatory signaling). More recent work
in our laboratory indicates that cell metabolism may be an important contributor to this process.
Specifically, a glycolytic shift is induced by inflammatory signaling. This glycolytic shift is required for
the transdifferentiation of fibroblasts to ECs. Thus, regulating cell metabolism within fibroblasts to
facilitate their transdifferentiation into reparative ECs may be a novel strategy for the treatment of
ischemia. To determine the molecular metabolic pathway that leads to transdifferentiation, we will
pursue experiments to trace key metabolites and demonstrate their importance in mediating DNA
accessibility and transdifferentiation. we will alter the function of a key metabolic enzyme to confirm
our proposed pathway, and finally, demonstrate the metabolic regulation of transdifferentiation in a
mouse model of peripheral artery disease (PAD). Completion of these studies will demonstrate the
novel concept that metabolic regulation within cells contributes to their fate and provide novel targets
to enhance this process for the treatment of PAD.

Public health relevance
Our laboratory has identified a role for glycolysis in transflammation and studies proposed here will characterize the dependency of acetyl-CoA metabolism on innate immune activation and identify the epigenetic effects of acetyl-CoA during transdifferentiation. Further, we will confirm the role of glycolysis in transdifferentiation using an established mouse model of peripheral artery disease. Completion of these studies will provide a novel pathway utilized by cells undergoing fate determination.